Structure and Function of the Essential Cell Cycle Regulator Cdc34

Project Summary
Post-translational modification of proteins by ubiquitin (Ub) is a regulatory mechanism that controls nearly
all aspects eukaryotic cell biology. Ubiquitination alters properties of target proteins such as stability,
subcellular localization, intermolecular interactions, and activity and thereby regulates processes such as
cell cycle control, DNA repair, signal transduction, and immunity. The relevance of Ub signaling to human
health is underscored by the fact that its dysregulation is implicated in pathologies such as cancer,
cardiovascular disease, and immune disorders and that it is a validated target for therapeutic intervention in
cancer with FDA-approved medications extending the lives of multiple myeloma patients.
Ub signaling requires the sequential interactions and activities of three enzymes, E1, E2, and E3, which act
in tandem to conjugate Ub to target proteins. The largest family of E3s, with more than 200 members, are
cullin-RING E3 ligases (CRLs) which are modular, multi-subunit complexes involved in a diverse array of
biological processes by functioning with the E2 Cdc34 to recognize substrates and catalyze the extension of
lysine 48-linked polyubiquitin (K48-polyUb) chains that signal for proteasomal destruction. One of the best
characterized CRL subfamilies are Skp, Cullin, F-box (SCF) RING E3 ligases which control cell cycle
progression by catalyzing K48-polyUb chains on key regulatory proteins at defined timepoints. CRLs are
also of intense interest therapeutically as they are hijacked by proteolysis targeting chimeras (PROTACs) to
catalyze K48-polyUb assembly on therapeutically important target proteins of interest. Despite their
fundamental importance biologically and therapeutically, many key questions regarding how Cdc34 and
SCF/CRL E3s function together at a molecular level remain, including: 1) How do Cdc34/SCF complexes
specifically catalyze K48-polyUb as opposed to other types of polyUb chains?, 2) What is the architecture of
the complete Cdc34/SCF E3/substrate/Ub donor/Ub acceptor complex during catalysis?, 3) What is the
structural basis by which CRLs catalyze PROTAC-mediated ubiquitination of substrate proteins?.
Through use of structural, biochemical/biophysical, and cell-based approaches, this proposal aims to
determine the structural basis by which Cdc34 and SCF function together to specifically assemble Lys48-
linked polyUb chains to control the cell cycle (Aim 1) and to determine the molecular mechanisms by which
PROTAC molecules with therapeutic potential hijack CRL E3 ligases to target proteins of interest for
ubiquitination and proteasomal destruction (Aim 2). Studying the system through this lens provides a unique
opportunity to gain deeper insights into both basic mechanisms of Cdc34/SCF/CRL E3 function as well as
into the mechanisms and molecular rules governing design of effective PROTACs that could ultimately
provide a platform for the development of novel therapeutics for cancer and other human pathologies.

Public health relevance
Project Narrative CDC34 and SCF/CRL E3 ligases function together to control myriad cellular processes such as cell cycle progression, a process essential to life that when dysregulated is a defining feature of cancer cells. CRL E3 ligases are also hijacked by PROTAC molecules which harbor therapeutic potential by inducing degradation of proteins of interest that contribute to human disorders. Successful completion of the proposed studies will reveal the molecular mechanisms by which Cdc34 and SCF/CRL E3s function together as essential regulators of key cellular processes and will provide a platform for development of novel cancer therapeutics.